Overcoming Therapy Resistance in Fusion Oncoprotein Driven Pediatric Leukemia

PROJECT SUMMARY
Leukemia represents the most prevalent form of cancer among children. Sequencing studies from
identical twins indicate that the initial genetic alterations can manifest as early as during fetal development. Acute
myeloid leukemia (AML) is a heterogeneous disease, which is characterized by various genetic alterations
including fusion oncoproteins. NUP98-NSD1 fusion-positive AML is a poor prognostic subtype that is commonly
diagnosed in pediatric patients with cytogenetically normal AML. There, the nuclear pore complex member
NUP98 fuses to the histone methyltransferase NSD1. Recently, NUP98-NSD1 gene fusions, in combination with
transcription factor WT1 (Wilms' tumor 1) mutations, were identified in a chemotherapy resistant pediatric AML
cohort, with a devastating 4-year event-free survival of less than 10%. The underlying reason why NUP98-NSD1
with WT1 mutations are associated with therapy resistance and relapse is not known.
In preliminary experiments, we created a humanized system of NUP98-NSD1 rearranged leukemia with
endogenous expression of the fusion gene, with and without WT1 loss of function mutations. Strikingly, NUP98-
NSD1 fusion-driven leukemogenesis displayed a developmental dependency, where its expression transforms
pre-natal fetal liver-derived hematopoietic stem cells (HSCs), to a lesser extent post-natal cord blood-derived
HSCs, but unable to transform adult bone marrow-derived HSCs. In vitro, endogenous NUP98-NSD1
oncoprotein conferred clonal selection and proliferation advantage in fetal HSCs, while in vivo, through
xenotransplantation in mice, NUP98-NSD1 faithfully recapitulated AML. Therefore, we hypothesize that the
epigenetic state of fetal-derived HSCs is permissive of NUP98-NSD1-mediated leukemic transformation, but is
repressed in developmental states after birth.
The overall objective of our project is to define mechanisms of action of NUP98-NSD1 in HSCs across
development, understand how WT1 mutations drive therapy resistance and identify novel therapeutic targets for
NUP98-rearranged leukemia. In Aim 1, we are proposing to investigate the cellular and developmental
dependency of NUP98-NSD1-mediated leukemic initiation by xenotransplantations. We will assess the single-
cell epigenetic and transcriptional landscape of NUP98-NSD1 fusion-positive HSCs across ontogeny. In Aim 2,
we plan to characterize the downstream effects of WT1 mutations in NUP98-rearranged leukemia. We observed
that concurrent WT1 loss led to a more primitive stem cell hierarchy and an enrichment of quiescent leukemic
stem cells. Finally, in Aim 3, we are proposing to identify therapeutic approaches against NUP98-rearranged
leukemia. We will functionally assess the role of candidate genes using our established model and primary PDX
patient samples. Our goal is to characterize novel therapeutic targets for NUP98-rearranged leukemia.
The proposed research has the potential to change our understanding of why children are susceptible to
NUP98-NSD1 rearranged AML and provide a strong rational for therapeutic intervention in the future.

Public health relevance
PROJECT NARRATIVE NUP98-NSD1 fusion-positive acute myeloid leukemia (AML) is a poor prognostic subtype in children and is frequently associated with co-occurring mutations in the transcription factor WT1. Focusing on the cellular and developmental context, our proposal aims to dissect mechanisms of action of the fusion oncoprotein NUP98- NSD1, investigate WT1's role in therapy resistance, and identify novel therapeutic targets for childhood AML. These results are poised to reshape our understanding of childhood susceptibility to AML and provide a rationale for therapeutic intervention in future clinical studies.